The Impact of an Intervention to Reduce Pharmacists' Racial Bias Towards People of Color at Risk of HIV

Project Summary: Significance: Although disproportionally affected by HIV, people of color experience
significant disparities in the pre-exposure prophylaxis (PrEP) care continuum. The accessibility of community
pharmacies and patient trust in pharmacists suggest that pharmacists can contribute significantly to increasing
equity in PrEP care. Pharmacist-led PrEP programs are expanding in the United States, with positive outcomes
in PrEP initiation and retention in care for those taking PrEP. Despite great potential for pharmacy-based PrEP
care, implicit racial bias is common among healthcare providers, including pharmacists, and may reduce the
effectiveness of pharmacist-led PrEP delivery. Candidate: I am a Ph.D.-level pharmacist with a strong
foundation in general pharmacy-related research; however, my research interests have pivoted in recent years
to HIV and racial disparities in care. My long-term goal is to become an independent NIH-funded clinical
investigator focused on developing and implementing pharmacy-based interventions to reduce healthcare
disparities in HIV treatment and prevention. I am therefore pursuing additional mentored training in key areas for
this new career path. Training aims: I propose training in (1) designing and conducting qualitative research
using implementation science frameworks; (2) implicit bias intervention adaptation; (3) simulation-based learning
in healthcare research; and (4) designing and executing clinical trials. Mentor team: Dr. Jessica Haberer
(primary mentor; clinical trials), Dr. Sheree Schwartz (implementation science), Dr. Nao Hagiwara (healthcare
providers’ bias and racial disparities), and Dr. Christina Psaros (qualitative methods. Advisor team: Dr. Musie
Ghebremichael (statistical methods), Dr. Aleda Chen (cultural competency), and Dr. Samreen Vora (simulation).
Research aims: The primary goal of this proposal is to determine the feasibility, acceptability, and preliminary
impact of an adapted, evidence-based intervention to reduce implicit racial bias among pharmacists who have
experience with or are willing to prescribe PrEP. In Aim 1, I will use a qualitative approach with the Health Equity
Implementation Framework to elicit the opinions of pharmacy interns, pharmacy managers, and policymakers
on relevant factors for implementing an evidence-based intervention to reduce bias. In Aim 2, I will use Aim 1
data to adapt the intervention to fit community pharmacy settings. In Aim 3, I will conduct a pilot trial with 70
pharmacy interns who will be randomized 1:1 to the adapted intervention vs control (a course on implicit bias) to
test the feasibility, acceptability, and preliminary impact of the adapted intervention in reducing implicit bias.
Feedback on the trial findings will also be obtained through interviews of pharmacy managers and policymakers.
Impact: Based on my solid foundation in pharmacy practice research, outstanding multidisciplinary mentoring
team, a strong institutional commitment, and this innovative research area, I am well-positioned to complete this
project, achieve my training goals, and become an independent clinical investigator to committed to reducing
healthcare disparities among disadvantaged people with HIV or those at risk of acquiring the infection.

Public health relevance
Project Narrative: People of color are disproportionately affected by HIV and experience substantial disparities in the preexposure prophylaxis (PrEP) care continuum. The accessibility of community pharmacies and patient trust in pharmacists suggest that pharmacists can contribute significantly to increasing equity in PrEP care; however, implicit racial bias is common among healthcare providers, including pharmacists, and may reduce the effectiveness of pharmacist-led PrEP delivery. The primary aim of this project is to identify the feasibility, acceptability, and preliminary impact of an adapted evidence-based intervention in reducing implicit racial bias among pharmacists who have experience with or willing to prescribe PrEP in the future.